Myoferlin in muscle membrane fusion and repair

PROJECT SUMMARY
Muscle injury is often accompanied by disruption of the muscle plasma membrane, and disruption of the
muscle plasma membrane leads to muscle injury. The elongated nature of skeletal myofibers, while optimized
for muscle contraction, places stress and strain on the sarcolemma through direct and lateral force
transmission. Mutations in genes encoding dystrophin and its associated proteins are associated with a fragile
plasma membrane that is more susceptible to rupture. Loss-of-function mutations in the dysferlin gene cause
muscular dystrophy through abnormal muscle membrane trafficking, which includes defective sarcolemmal
repair. An improved understanding of the membrane repair machinery of muscle will not only provide useful
information for developing novel approaches to treat dysferlinopathies, but also will provide insight for muscle
repair in many forms of muscle injury. Muscle injury occurs with disease, intense exercise, trauma, and
surgery, and enhancing muscle repair may benefit each of these needs. Dysferlin, and the highly related
myoferlin, are membrane-anchored proteins with multiple C2 domains, domains known to have protein and
phospholipid binding properties. We used high-resolution microscopy and real time live imaging to define
distinct subcomplexes within the sarcolemma repair machinery. The first subcomplex is the repair cap, which
forms within seconds after membrane disruption. The repair cap is enriched for annexins, including annexins
A6, A2, and A1. Immediately beneath this cap within the cytoplasm is an annexin-free zone enriched with
filamentous actin. The repair cap is surrounded by a ring of shoulder proteins that include dysferlin, EHD
proteins, BIN1 and others. The shoulder region is enriched for phosphatidylserine indicating the importance of
phospholipid signaling for sarcolemmal repair. The repair cap and the shoulder ring are independent
structures. We propose a model in which calcium and phospholipid signaling orchestrate the assembly of the
repair complex in muscle by first organizing annexin caps. In this model, phospholipid signaling drives
assembly of the ring of shoulder proteins, which requires their membrane-bending capacity. We will test this
model of sarcolemmal repair using laser injury and high resolution imaging in isolated muscle fibers. We will
also evaluate this model in the context of in vivo muscle disease and injury. The first aim will conduct
experiments to delineate annexin assembly with focus on the role of calcium as a trigger for repair cap
formation. The second aim concentrates on defining the role of dysferlin and its interaction with BIN1 and EHD
proteins in forming the shoulder ring. The third aim outlines experiments to improve muscle membrane repair.
These studies will decipher repair complex interactions with the goals of mitigating sarcolemmal injury and
improving muscle repair.

Public health relevance
PROJECT NARRATIVE Muscle injury occurs after intense exercise, due to trauma and surgery, and muscle heals by way of repair and regeneration, and we developed a new system in which we can now visualize the repair complex as it reseals disrupted muscle membranes. Using this method, we will define how the repair subcomplexes assemble and define how these complexes function during muscle injury and in muscle diseases like muscular dystrophy. The findings from this work are not only relevant during muscle recovery but also for the treatment of chronic muscle diseases like the muscular dystrophies.